Low-voltage liquid lens enabled endoscopic optical coherence tomography

Project Summary
This is an application in response to FOA number, PAR-24-022 (NIBIB), “Trailblazer Award for New and Early
Stage Investigators (R21 Clinical Trial Optional)”. Recently, we demonstrated non-mechanical scanning for
imaging. This technology can be used for a miniature forward-viewing endoscopic micro-optical coherence
tomography (µOCT) system to image tissue during surgery. The endoscope will enable great insight into human
illnesses such as cardiovascular disease, cancer, and neurological disorders. While µOCT is a mature technology,
miniaturization of a system into a probe has faced challenges. Galvos are large and bulky, MEMs mirrors (both
electrostatic and electrothermal) require non-negligible powers, mechanically moving parts, and are limited in
speed. In contrast, our endoscopic probe relies on a compact, non-mechanical electrowetting adaptive optical
component that shows great promise for imaging applications. We will first validate our device by designing and
demonstrating a low-voltage component operating at kHz speeds. Next, we will develop a miniaturized µOCT
endoscope system with an integrated electrowetting prism scanner. We will demonstrate both systems on
phantom tissue. The results can be used to extend the technology to imaging the cardiovascular system.
AIM 1: TECHNICAL APPROACH Demonstrate kHz spectral-domain µOCT using a low voltage electrowetting
prism scanner
AIM 2: TECHNICAL APPROACH Demonstrate a miniaturized µOCT endoscope system with an integrated
electrowetting prism scanner

Public health relevance
Project Narrative A current challenge for cardiologists is the ability to generate high resolution images of the heart. This is driven by the lack of compact forward-viewing endoscopic micro-optical coherence tomography systems. In the proposed research, we will develop an innovative compact endoscope containing a low-voltage electrowetting adaptive element with an ultimate goal of forward-viewing endoscopic micro-optical coherence tomography in a surgical setting.